Translating research to practice in corrections staff mental health through dissemination of evidence: from pilots to practical programs

Title: Translating research to practice in corrections staff mental health through dissemination of
evidence: from pilots to practical programs
PROJECT SUMMARY
Our collaborative series of research-to-practice (r2p) conference meetings will advance evidence-based
interventions to reduce stress and trauma that contribute to chronic health issues among this high-risk
workforce. We will utilize r2p methods to advance correctional worker mental health and well-being, through
awareness and directed utilization. We will oversee the dissemination of evidence and its conversion to
practice in three conference meetings. We intend to listen to worker voices, gain feedback from attending
correctional workers and their lived experiences, promote the evaluation of interventions, and inform the
usefulness and utilization of evidence-based resources. This innovative annual series builds upon each event
and existing best practices, informing the next one to advance interventions.
Our efforts to advance r2p in corrections worker health is supported by 15 years of research and locally based
practice, and experience building a participatory network of key stakeholders and change agents. Vehicles
include hosting three National Corrections Collaborative (NCC) Symposia (CPH-NEW, 2022; El Ghaziri, et al.,
2020); and a National Institute of Corrections (NIC) cooperative agreement project to identify resource
provision and resource gaps to address organizational stress and trauma among corrections workers. We will
optimize conference attendance by echoing our past tandem format that coordinates these NIOSH supported
conferences with regular national corrections meetings.
Our research has confirmed that serious health issues affect this public safety sector workforce, and that these
are exacerbated by violence, trauma, and stress that occur intrinsically in correctional work environments
(Jaegers et al., 2022; 2019; Obidoa et al., 2011). Corrections officers are disproportionately burdened by
fatalities from violence, by high rates of non-fatal injuries from assaults and involvement in violent events, and
by high rates of homicide and suicide in inmates, and (Konda, et. al., 2012). Rates of mental disorders in COs
exceed other criminal justice professions and the general public, with 53% of jail officers meeting the criteria
for PTSD (Jaegers et al. 2019) and 31% for depression (Jaegers et al., 2020; NIJ, 2016).
Our recent NIC investigation revealed the scarcity of intervention research to address the mental health needs
of corrections workers. Our scoping literature review for NIC identified only 25 studies in 7 categories that
were suitable for building an inventory (policies, practices, peer support, and training) suitable for addressing
worker trauma and organizational stress. Through our partnership with NIC we have engaged and expanded
the NCC Project Taskforce (NCC-PT) to 41 active members representing correctional workplaces,
researchers, unions, and professionals critical to informing conference meeting design and evaluation.

Public health relevance
PROJECT NARRATIVE Our collaborative series of research-to-practice (r2p) conference meetings will advance awareness, utilization and study of correctional worker mental health and well-being resources to reduce stress and trauma that contribute to chronic health issues among this high-risk workforce. They are based on our past symposia design that complimented national corrections organization events and were informed by a national, collaborative taskforce of key informants on correctional workplaces, lived experience, research, and union advocacy. Bridging findings from our recent national prison and jail survey and scoping review to address the usefulness and helpfulness of current and evidence-based practices will inform the quality of resources and dissemination of best practices to correctional workplaces and users.